Regulation Of Metabolism And Gene Expression By Iron-Sulfur Clusters - Supplement

Project Summary/Abstract (from original application)
Iron-sulfur clusters (ISCs) are essential protein cofactors whose dysregulation is linked to a wide range of
debilitating diseases including Friedrch’s ataxia. This pathology is due in part to the use of ISCs in iron responsive
proteins (IRPs), which control the translation of mRNAs in the iron-starvation response. We recently found that
by suppressing ISC biosynthesis we can robustly activate this IRP-mediated iron-starvation response, sensitizing
cancer cells to cell death by ferroptosis. Our preliminary data, which form the premise of our application, point to
an unexpected mode of IRP2 regulation by ISCs and demonstrate that the mechanism by which ISCs modulate
the iron-starvation response, and therefore impact human disease, remains unclear. Our long-term goal is to
dissect the mechanisms by which ISCs regulates cellular responses to changing iron and oxygen availability and
how this response is mediated by IRPs. We anticipate that these discoveries will lead to the identification of
pathologies for diseases where prior ISC involvement was unclear, to new treatments for diseases of ISC
dysregulation, and will facilitate novel methods to sensitize cancer cells to ferroptosis. The objective of this grant
is to dissect how ISCs control IRP2 activation and to comprehensively define the targets of IRP1 and IRP2 and
the conditions under which they are activated. Our overarching hypothesis is that ISCs integrate iron and oxygen
level inputs to effect specific translational responses via differential regulation of IRPs. Our rationale is that
identification of the specific mechanisms by which IRPs are activated and the targets that they activate will enable
the discovery of novel strategies to treat cancer and disorders of ISC metabolism. Our specific aims will test the
following hypotheses: (Aim 1) ISCs can activate the iron-starvation response through an IRP2-mediated
mechanism; (Aim 2) IRPs exhibit differential IRE binding in response to iron and oxygen level modulation. Upon
completion of these aims we will (1) gain an understanding of how cells sense iron and oxygen levels and
integrate these inputs using ISC sensors and (2) identify IRP regulated target genes and the conditions in which
they are regulated. This contribution is significant because dysregulation of IRPs occurs frequently in human
pathologies, and inducing activation of the iron starvation response sensitizes cancer cells to ferroptotic cell
death. This research is innovative because we challenge paradigms in cellular iron-sensing to arrive at a
comprehensive mechanism by which cells respond to changes in the level of this important nutrient, and because
we utilize heretofore unique approaches to identify RNAs regulated by the iron starvation response and define
their activation by upstream stimuli. The outcomes of this study promise disrupt our understanding of iron sensing
and have broad implications for the treatment of cancer as well as human diseases related to defects in iron
metabolism and storage.

Public health relevance
Project Narrative (from original application) Iron-Sulfur Clusters (ISCs) are protein cofactors required for the function of at least 48 human proteins. Defects in ISC biosynthesis are present in numerous human syndromes including heritable forms of systemic iron overload due in part to the use of ISCs in iron-responsive proteins (IRP), which are used as molecular iron and oxygen sensors. Using cellular and murine models of ISC and IRP dysfunction, we will explore how these molecular sensors regulate the cellular response to oxygen and iron.